Advancing Disease Modeling through Mathematical Frameworks: Leveraging Single-Cell Spatial Data to Uncover Tissue-Specific Pathways and Immune Responses

Project Summary
The rapid advancement of single-cell spatial imaging technologies, such as Spatial Transcriptomics, Imaging Mass
Cytometry (IMC), and CODEX (CO-Detection by Indexing), has revolutionized our understanding of tissue
microenvironments by offering unprecedented insights into the spatial organization and interactions of diverse
cell types within tissues. These technologies generate large, complex datasets that capture the heterogeneity and
dynamic behaviors of tissues at single-cell resolution. However, there remains a significant need for advanced
mathematical models that can fully leverage these datasets to interpret the complex biological processes involved.
This project seeks to bridge that gap by developing sophisticated mathematical models, particularly using partial
differential equations (PDEs), to investigate the spatial interactions between cells and molecules within tissues.
Specifically, the models will aim to capture tissue-specific biochemical and biomechanical characteristics to uncover
the pathways and mechanisms that influence various diseases and immune responses. Understanding these key
factors is essential for revealing how tissue microenvironments regulate disease progression and immune interac-
tions. For example, modeling interactions in bone tissue can elucidate mechanisms responsible for conditions like
aging, bone deformation, autoimmune diseases such as rheumatoid arthritis (RA), and cancer.
By integrating both mechanical and biochemical dynamics into our models, we will develop a comprehensive
framework for understanding multi-scale interactions in disease contexts. These models will also serve as predictive
tools to simulate how different interventions may influence disease progression and immune responses in various
tissues.
The spatial dependence introduced in the PDEs will help model the movement of cells, cytokines, and other
signaling molecules within tissue environments, a critical factor for processes such as inflammation, immune
responses, and tissue remodeling. Ultimately, this project will contribute to the discovery of novel therapeutic
targets and the development of personalized treatment strategies by providing a deeper understanding of the
pathways and mechanisms that drive complex diseases across different tissues.

Public health relevance
Project Narrative This project aims to develop advanced mathematical models using partial differential equations (PDEs) to analyze the spatial interactions between cells and molecules within tissue microenvironments, leveraging rich single-cell spatial imaging datasets. By incorporating tissue-specific biochemical and biomechanical factors, the models will uncover the pathways and mechanisms driving disease progression and immune responses across different tissues, such as bone, where conditions like cancer and autoimmune diseases arise. These models will also serve as predictive tools, enabling researchers to test how various interventions impact disease and immune dynamics, ultimately guiding the development of personalized treatments.